Breaching the Tumor-Immune Mechanical Barrier for Optimal Antitumor Immunity

Project Summary/Abstract
Tumor immune exclusion predicts poor anticancer therapeutic responses and patient outcomes. The mechanical
barrier built by intercellular junction connections and extracellular matrix maintains immune exclusion in immune-
privileged organs. How such barriers dictate immune infiltration in cancer remains largely unknown. My prior
training and career goals are focused on the unmet need to comprehensively understand what mechanical
barriers are utilized by tumors, how they instigate immune exclusion to evade immune surveillance, and how to
rationally design innovative therapies that break down mechanical barriers and unleash the full potential of
antitumor immunity. Since joining the Ellisen Lab at Massachusetts General Hospital/Harvard Medical School, I
have focused my mechanical barrier studies on the tight junction related molecule TROP2, which is
overexpressed and thought to play a role in progression of multiple cancers including aggressive triple negative
breast cancer (TNBC). Like its paralog EPCAM, TROP2 is one of a set of mechanical barrier molecules linked
to lack of tumor infiltrating immune cells. Additionally, my preliminary bioinformatic analysis shows that TROP2
has a significant negative correlation with key antitumor immune markers in multiple breast cancer cohorts. Thus,
I hypothesized that TROP2 may enforce a mechanical barrier to deter antitumor immune infiltration in breast
cancer. Importantly, TROP2 is the target protein of multiple recently developed antibody drug conjugates (ADCs)
including Sacituzumab Govitecan (SG). SG, the first FDA approved ADC for TNBC, combines a TROP2-targeted
antibody with a topoisomerase 1 (TOP1) inhibitor as cytotoxic payload. While SG is proving to be a highly
successful precision therapy, its mechanisms remain poorly understood. Furthermore, the cytotoxic payload of
SG is a TOP1 inhibitor, a class of drugs known to elicit immunogenic cell death, thus providing a strong rationale
to understand mechanisms by which targeting TROP2 alone and in the context of SG will modulate tumor
immune microenvironment, thus sensitizing tumors to immune checkpoint inhibitors. This proposal will employ
biochemistry, mouse tumor models, genetic screens, as well as multi-omics and spatial imaging analysis of
patient specimens. The study aims to dissect the mechanism of TROP2-mediated immune exclusion in TNBC
(Aim 1); discover mechanisms of the SG/anti-PD1 combination (Aim 2), and systematically uncover novel
instigators of breast tumor immune exclusion (Aim 3). My extensive background in breast cancer immune
microenvironment and the interdisciplinary expertise of my mentor/advisors/collaborator team make me well-
suited to carry out this innovative proposal to systematically unravel tumor-intrinsic mechanisms of immune
exclusion. Together with the institutional support from Massachusetts General Hospital/Harvard Medical School,
this award will help me gain additional knowledge and training in the area of tumor models, spatial multi-omics
analysis, and CRISPR screens, as well as career development skills which will ultimately help me to rapidly
transition to a fruitful and impactful independent research career.

Public health relevance
Project Narrative Despite the successful development of multiple immunotherapeutic modalities, tumor immune exclusion mechanisms prevent many patients from reaping their benefits. Recent models suggest that tumors actively enforce a mechanical barrier at the tumor-stroma periphery to exclude antitumor immune infiltration and to prevent subsequent immune-mediated killing. This proposal seeks to systematically dissect the components of the tumor-immune mechanical barrier through approaches including in vivo preclinical mouse models, genetic screening, and multi-omics spatial analysis of patient specimens, which will reveal unanticipated immune suppressive mechanisms utilized by cancer and thereby shed new light on novel anticancer treatment strategies.